A Research Study on Contaminants in School Meals: Ithaca Healthy School Meals

PROJECT SUMMARY / ABSTRACT
This pilot study will generate the first systematic evidence on contaminant levels in National
School Lunch Program meals and an initial assessment of how menu composition affects
contaminant exposure. By implementing a rigorous pre-post intervention design, the research
will advance scientific understanding of whether food processing levels directly impact
contaminant burden in institutional food service settings. The study will also contribute novel
data on the feasibility and effectiveness of large-scale menu transitions in institutional settings.
The evaluation of whole food menu implementation using scratch-cooking practices will provide
insights into optimal transition strategies and identify key barriers and facilitators for sustainable
program changes.
A primary goal of this research is to measure the current levels of contaminants and UPFs in
school meals and to offer effective strategies that promote the inclusion of fresh, whole, and
minimally processed foods. We offer a new methodology utilizing a standardized instrument (a
“scratch cooking worksheet”) to understand an SFA’s current position along the scratch-cooking
continuum as a proxy measure for the availability of UPFs, thereby prioritizing a solutions-based
approach. The current research on both UPFs and scratch cooking in schools is nascent; if we
are successful, we will address a critical gap in knowledge about the current prevalence of
UPFs in school meals as well as offer a new methodology for measuring scratch cooking that
can be replicated across more districts, states, and nationally.
The Chef Ann Foundation (CAF), a non-profit dedicated to promoting whole-ingredient,
scratch-cooking in schools, will support Ithaca City School District, based in Ithaca, New York,
with project implementation. The district serves 5,383 students across twelve school sites.
Project research activities will be carried out at eight sites. UPFs and selected contaminants will
be measured at baseline assessment and in post-evaluation. The district will receive technical
assistance from CAF to complete menu transitions to scratch-cooked offerings in the 2025-2026
school year, with midpoint adjustments made based on first-semester results and challenges. A
final report will demonstrate the operational improvements made by the district in moving toward
a more whole-foods menu. Additionally, results from the pre-post assessment will inform the
larger study to assess UPFs and contaminants in school meals.

Public health relevance
PROJECT NARRATIVE This pilot study directly supports the FDA's initiative to evaluate the safety and nutritional quality of National School Lunch Program (NSLP) meals, representing a critical federal response to this public health concern. The systematic evaluation of contaminant levels and ultra-processed foods in school meals, along with the implementation of scratch-cooking practices that prioritize whole ingredients, addresses both immediate food quality concerns and long-term chronic disease prevention through improved meal quality. By validating Chef Ann Foundation’s scratch cooking worksheet and systems change approach to scratch cooking, we offer a cost-effective alternative for NSLP programs to reduce harmful contaminants, including heavy metals and UPFs, in school meals.